Preschoolers Learning & Active in Play (PLAY)

PROJECT SUMMARY
Physical activity in early childhood is important for numerous aspects of children's health and development.
Preschoolers are thought to be very active but previous studies have shown that they are sedentary for the
majority of time and not getting adequate opportunities to engage in active play. Experts have recommended
strategies to promote physical activity in early learning settings and to involve parents in efforts to promote
active living from a young age. Through early learning settings, we may be able to change behaviors in large
groups of children and particularly benefit more vulnerable children who have fewer opportunities for outdoor
play and physical activity at home or in their neighborhoods. However, meaningful engagement from families is
also important and research suggests that there is gap in communication and perhaps alignment between
educators and parents on the topic of preschoolers' physical activity. We propose research that uses wearable
technology to monitor physical activity in children, motivate parents and educators to help create active play
opportunities, and create a platform for communication and shared accountability about this important health
behavior. We will focus particularly on children from lower income backgrounds who suffer from disparities in
both health and educational outcomes. In the 2-year R21 phase we propose to evaluate the feasibility,
acceptability, and potential efficacy of a 6 month preschool-based, multi-level intervention to promote
preschoolers' physical activity using wearable technology and incrementally intensive behavior change
techniques to enhance engagement of parents and educators. In the first condition we study, preschoolers and
their educators will get wrist-worn activity trackers called Sqord to monitor daily activity levels. In the second
condition, we will study whether also giving parents activity trackers and weekly feedback reports about their
own and their child's activity help promote more physical activity. Finally, in the third condition, we will add on
training and coaching for early childhood educators to align the physical activity intervention with the metrics
they are familiar with and evaluated on from an early learning standpoint. We will use the results from the R21
to inform the intervention strategies we include and test more rigorously in the 3-year R33 phase. Our primary
outcome of interest is accelerometer measured physical activity. In the R33, we will also explore how changes
in preschooler's physical activity relate to cognitive and behavioral indicators of kindergarten readiness, which
are topics of great significance to early childhood educators, policy makers and parents.

Public health relevance
PROJECT NARRATIVE Preschoolers are thought to be very active but many are not getting adequate opportunities for active play and the recommended amounts of physical activity needed for their health and cognitive development. Experts have recommended strategies to promote physical activity in early learning settings and to involve parents in efforts to promote active living from a young age. We propose research that uses wearable technology to monitor physical activity in children and motivate parents and educators to help create those active play opportunities, particularly for children from more vulnerable backgrounds who suffer from disparities in both health and educational outcomes.